Selective interactome vulnerability across the Alzheimer’s disease spectrum

ABSTRACT
Mechanisms underlying selective vulnerability from cells to networks across the Alzheimer's disease (AD)
spectrum remain unknown, limiting our understanding of disease and hampering development of effective
therapies. We propose to identify protein-protein interaction (PPI) network dysfunctions in brain cells and regions
as a gateway to selective vulnerability mechanisms in AD. To gain systems level insights, we propose to leverage
our discoveries in stress biology linking interactome network perturbations to the formation of long-lived
oligomeric scaffolds termed epichaperomes, and to employ a novel `omics platform called epichaperomics that
provides direct information on PPI network changes. Preliminary studies indicate epichaperomes change how
thousands of proteins interact and negatively impact PPI networks important for neuronal function, including
synaptic plasticity, cell-to-cell communication, protein translation, cell cycle re-entry, axon guidance, metabolic
processes and inflammation, leading to cell and connectome-wide dysfunction and cognitive decline. Parallel
studies in transgenic mice and iPSC-derived neurons demonstrate epichaperome formation is a key event that
negatively impacts cellular function, from early prodromal disease stages and throughout disease progression.
Preliminary results in transgenic mice and postmortem AD brains suggest epichaperome formation occurs
principally within vulnerable brain cells and regions. Accordingly, we hypothesize epichaperome formation, and
in turn of epichaperome-mediated PPI network imbalances, over decades, not only results in defects within
intrinsic neuronal proteins and protein pathways but also intercellularly, where it disrupts intrinsic network
connectivity of cells and of brain circuits. We posit vulnerable neurons and brain regions have a higher propensity
to accumulate epichaperomes, and epichaperome-mediated dysfunctions. In accordance with NOT-AG-21-040,
we propose to uncover mechanisms of PPI dysfunctions within individual brain cells and regions as a portal into
selective vulnerability in AD, which remains unknown and a key missing piece. We aim to i) investigate
mechanisms that enable (i.e., epichaperomes, Aim 1) and ii) those that execute (i.e., impacted proteins and
protein pathways, Aim 2) context-specific dysfunctions in PPI networks. As a key element in linking stressors-to-
phenotype, we aim to uncover cell- and region-specific vulnerabilities within PPI networks induced by individual
stressors (Aim 3). Results provide first-of-a-kind insights into the spatio-temporal formation and distribution of
epichaperomes across the AD spectrum and their relationship to clinical, pathologic, and genetic vulnerabilities.
Outcomes are critical proteome-wide insights into interactome vulnerabilities, both on the nature and trajectory
within vulnerable brain cells and brain regions. Raw datasets and data analytics will be deposited directly into
free access sites for mining and hypothesis testing by members of the scientific community. In addition to defining
technically challenging mechanistic insights into selective AD vulnerabilities, innovation includes diagnostics and
therapeutics, as epichaperome-mediated dysfunctions are both imageable and targetable.

Public health relevance
NARRATIVE Understanding mechanisms underlying selective vulnerability from cells to networks in Alzheimer's disease (AD) is critical to define the disease process and to develop effective therapies. We present an innovative, multidisciplinary strategy to investigate factors underlying selective vulnerability, from brain cells to brain regions, across the AD spectrum, a high-priority topic of interest under PAR-22-093, NOT-AG-21-040. The outcomes are highly relevant insights, of both mechanistic and therapeutic importance.